Development and Evaluation of CRRT-Specific Precision Dosing Models to Optimize Beta-Lactam Treatment for Patients with Hospital-Acquired Pneumonia

Project Abstract
Hospital-acquired pneumonia (HAP) caused by antibiotic-resistant pathogens such as Klebsiella
aerogenes, Klebsiella pneumoniae, and Pseudomonas aeruginosa are responsible treatment failure and
mortality rates up to 50% and 30%, respectively. Meropenem is a mainstay for the treatment of HAP, but
antibiotic resistance continues to erode its clinical efficacy. Importantly, the efficacy of beta-lactams
depends on achieving adequate pharmacokinetic-pharmacodynamic (PK/PD) exposures; however, many
patients with HAP experience inadequate PK/PD because of changes in PK caused by critically illness.
Precision Dosing strategies can overcome PK variability caused by critical illness, but Precision Dosing
requires robust models; such models for critically ill patients who develop kidney injury and require
continuous renal replacement therapy (CRRT) are currently lacking for HAP patients. Without Precision
Dosing models to help guide antibiotic dosing, these vulnerable patients will continue to experience high
rates of treatment failure and death. Whereas the status quo treatment of HAP patients requiring CRRT
uses population-based dosing schemes, our proposal will innovate Precision Dosing (i.e., individualized)
strategies for patients with HAP. We will leverage the infrastructure of the Successful Clinical Response In
Pneumonia Therapy (SCRIPT) Systems Biology Center to robustly address the unmet needs of patients
on CRRT. Our long-term goal is to develop Precision Dosing strategies that overcome PK variability
caused by severe illness. The project objective is to utilize the infrastructure, samples, and data collected
in SCRIPT to develop Precision Dosing models for HAP. Our central hypothesis is: (1) CRRT leads to
variability in beta-lactam PK with standard “one-size-fits all” HAP dosing regimens which (2) increases the
risk of clinical treatment failure in HAP, (3) requiring Precision Dosing schemes. The rationale for our
study is that Precision Dosing is needed for CRRT patients with HAP and that these approaches must be
translated clinically. In Aim 1, we will develop and qualify Precision Dosing models for meropenem in
CRRT. In Aim 2, we will describe meropenem PK/PD target attainment in plasma and in the lung for
patients requiring CRRT. In Aim 3, we will create a web-based dosing calculator for translation to practice.
Our study will have a positive clinical impact by providing clinicians with the tools necessary to
ensure that each patient’s dosing is optimized. This research is significant because it addresses a critical
unmet need for optimized therapy. Upon completion, our study will have robustly characterized alveolar PK
in CRRT patients, filling a gap in the rigor of prior research. We will have translated our Precision Dosing
model predictions into actionable dosing regimens, which is innovative as no such calculators exist. Our
Precision Dosing calculator will be evaluated in a future R01-funded randomized controlled trial.

Public health relevance
Project Narrative: The proposed research is relevant to public health because antibiotic resistant infections caused by Klebsiella aerogenes, Klebsiella oxytoca, Klebsiella pneumoniae, and P. aeruginosa were responsible for approximately $2 billion in attributable healthcare costs and over 12,000 deaths in 2017 alone. Nearly half of all patients who develop severe pneumonia caused by pathogens like these will experience antibiotic treatment failure and up to 30% will not survive. This proposal will advance the NIH mission to protect and improve patient health by addressing the urgent for new and innovative treatment approaches including Precision Dosing for patients infected by these pathogens.